Factors Impacting Global Health: The Importance of Individualized Treatment Goals for Black Breast Cancer Survivors

Project Summary/ Abstract:
This F31 award will allow Kelsey Sinclair (PI) the research training that will advance her toward her goal of
becoming an independent cancer multimorbidity scientist with an expertise in intervention adaptation and
implementation to optimize cancer care in underserved groups. Cancer-obesity co-morbidity is common and
especially deadly for Black breast cancer survivors (BCS). Although Black women have lower breast cancer
incidence, they have the highest breast cancer mortality rate (40%) of any U.S. race/ethnic group – an effect
attributed in part to comorbid obesity and systemic health disparities. Obesity predicts higher mortality among
Black BCS, and post-cancer diagnosis weight gain predicts increases in mortality. Treatment inequities due to
intersecting weight/race stigma also contribute to cancer screening/treatment delays. One way to fight back
against these disparities is to develop and to deliver obesity treatments adapted to address the unique challenges
of the Black BCS community. Identification of important risk/protective factors can be applied to evidence-based
weight loss interventions to provide inclusive, equitable, and potentially life-extending care. Thus, the proposed
multi-method study will use a socioeconomic framework and multi-methods to discover actual risk/protective
factors for Black BCS with obesity compared to other BCS. PI Sinclair will leverage resources from a parent trial
to first use a quantitative survey to assess 100 BCS from any race-ethnicity to test potential risk and protective
factors that differ for Black BCS (Phase 1). Second, using co-design qualitative methods, initial tailoring of an
evidence-based weight loss intervention for obesity will be done in collaboration with our patient partners – five
Black BCS with obesity (Phase 2). This tailored weight loss protocol will then be delivered in a pilot with 15 Black
BCS with obesity, with preliminary evaluation of potential treatment heterogeneity factors (Phase 3). Via these
phases, the following F31 aims will be addressed: Aim 1: To proactively identify cultural and multimorbid factors
of an obesity intervention for Black BCS and Exploratory Aim 2: To explore obesity treatment response in Black
BCS via subgroup analyses. We hypothesize that Black women with obesity will report the highest risk scores
and lowest protective scores, that qualitative interviews will identify important factors that may not have been
captured quantitatively, and that variables that emerged as relevant with adequate variability across the sample
will impact treatment response. The proposed F31 will thus utilize Phase 1 survey data and Phase 2 qualitative
interviews (Aim 1) as well as Phase 3 post-treatment data (Exploratory Aim 2). Accordingly, it will benefit from
the existing parent pilot infrastructure (e.g., recruitment strategies, participants, trial conduct). For the parent trial,
the outcomes are acceptability, feasibility, and preliminary weight loss of the program. PI Sinclair’s project and
training plan will allow for a comprehensive multi-method analysis of adaptation factors to inform future larger-
scale trials and foundations of a future F32 or K23 for PI Sinclair, a future scholar with expertise in multimorbidity
interventions in cancer, obesity, and other chronic diseases disproportionately impacting underserved groups.

Public health relevance
Project Narrative: Black breast cancer survivors with obesity are at an increased risk of poorer cancer-related outcomes, additional multimorbid conditions, and worse survival/greater mortality. This innovative multi-method study will identify protective and risk factors needed to tailor evidence-based weight loss interventions to address the unique challenges of Black breast cancer survivors – which will contribute to vital scientific and public health knowledge regarding intervention design for a population at high risk. Further, this project will serve as a valuable training opportunity for a young scholar to gain expertise in multimorbidity among underserved populations and how to adapt interventions targeting multimorbidity to advance equitable cancer care and treatment.